Postdoctoral Training Program in Genomic Medicine

Genomics technology is sufficiently advanced to measure DNA sequence variation and RNA expression in
clinical samples. However, the integration of genomic measurements into healthcare is outpacing the training
of physicians and scientists, and many are ill-equipped to use this information to improve the health of patients.
Thus, it is imperative to train the next generation of physician and scientist leaders in Genomic Medicine. We
propose to renewal our post-doctoral training program in Genomic Medicine focuses on translational medicine
and informatics and is led by Drs. Jason Moore, Edward Rose Professor of Informatics, and Director of the
Penn Institute for Biomedical Informatics, and Katherine Nathanson, Pearl Basser Professor of BRCA-Related
Research, and Deputy Director, Abramson Cancer Center. We provide a foundation for training in Genomic
Medicine, applicable to both MD and PhD trained fellows, recognizing that each may enter the program with
different skill sets and experiences. It essential to provide all fellows with a strong background framework so
that they can develop exciting and relevant projects in Genomic Medicine. Trainees enroll in a two-year
program, including didactic courses, clinical and laboratories rotations, interactive learning experiences and
research training. We require a balanced portfolio of courses, which cover the latest advances in genomics,
focused on the role of genomics in disease processes, quantitative sciences, including biomedical informatics
and biostatistics, scientific writing and ELSI issues. The 39 trainers were selected based on their expertise in
Genomic Medicine and come from multiple departments, which is further enlarged with clinicians experienced
in the provision of Genomic Medicine. The trainees are dually mentored in a research project by a balanced
team (e.g. clinician and basic scientist) experienced in Genomic Medicine. Trainees participate in clinical
rotations designed to give them experiences that range from the generation of massively parallel sequence
data to data analysis to reporting back the results to patients. Trainees also participate in interactive activities,
including a journal club, research in progress presentations, clinical genetics rounds and retreats. The
combination of coursework, experiential clinical rotations, participation in interactive activities, and mentored
research experience prepares our physicians and scientists for careers in Genomic Medicine. Over the past
five years, 14 individuals were accepted (42% of applicants) into the Genomic Medicine program - eight
physicians, six scientists, from 10 different departments and divisions at Penn Medicine (nine) and CHOP
(five). Nine (64%) of our trainees were women and three (21%) reported coming from underrepresented
populations. We have been privileged to attract an exceptionally strong and diverse set of trainees and
anticipate continuing to be able to do so. We request continued support for the entry of three trainees a year in
the Genomic Medicine T32 post-doctoral training program at the University of Pennsylvania.

Public health relevance
The provision of health care is undergoing a genomics revolution. With massively parallel sequencing as a disruptive technology, our understanding of the genetics and genomics underlying human disease is taking an exponential leap forward. However, few physicians and scientists have been trained to understand these data, let alone take advantage of them to translate into improvements in patient care. We propose to continue our post-doctoral training program for the next generation of physician and scientist leaders in Genomic Medicine in the Perelman School of Medicine, Penn Medicine, and the Children’s Hospital of Philadelphia. The program draws upon the extraordinary strengths at these institutions in the areas of genomics, translational medicine, and bioinformatics, and prepares the trainees to embark upon careers applying Genomic Medicine to the improvement of health care through advances in diagnosis, therapeutics and prevention.